The Impact of Stigma on Cancer Care Decision-Making Among Patients with Osteosarcoma and Retinoblastoma in Zimbabwe, Guatemala and Jordan

Abstract/Project summary This application is being submitted in response to the Notice of Special Interest (NOSI) identified as “NOT-CA-21-026”, as a supplement to the St. Jude Comprehensive Cancer Center (SJCCC) P30. A core objective of the SJCCC is to increase access to cancer care for children. As part of this goal, SJCCC seeks to understand the role of social and cultural factors (such as stigma) that influence cancer care acceptance and adherence globally. Stigma has been demonstrated to affect healthcare acceptance and outcomes for adult patients with a myriad of health conditions, including cancer. However, the impact of stigma on pediatric cancer care is understudied. Over 90% of children diagnosed with cancer live in low- and middle-income countries (LMICs). In these settings, stigma has been noted to affect quality of cancer care delivery and contribute to treatment abandonment, a leading cause of death for children with cancer in LMICs. Studies from individual institutions have alluded to the ways in which culture informs stigma, however no global or cross-regional work has been done to compare the manifestations of stigma across LMICs. The aims of this application are to 1) explore the ways in which stigma influences decision-making and cancer care acceptance in Guatemala, Jordan, and Zimbabwe, and 2) identify potential strategies and opportunities to mitigate stigma during cancer treatment and decision making. We will leverage longstanding partnerships through SJCCC and the Department of Global Pediatric Medicine to conduct an exploratory qualitative study at three national cancer centers in these geographically, culturally, and socioeconomically diverse settings. The Health Stigma and Discrimination Framework, a previously published model designed to facilitate global stigma research across healthcare conditions, will be used to design a semi-structured interview guide and analysis focused on stigma drivers and facilitators, as well as stigma experiences and practices. Three participant groups will be included: parents of children with cancer, adolescent patients, and healthcare providers. This will enable analysis based on the multiple perspectives involved in the pediatric care triad. This study will specifically focus on patients with osteosarcoma and retinoblastoma, as well as their parents and providers. Stigma is highly relevant for these diagnoses due to frequent need for appearance-altering surgery and these cancers offer a model to explore stigma among infant as well as adolescent patient populations. This study will be the first to explore how stigma-related concerns influence decision-making among pediatric oncology patients and families in LMICs, and how these effects might be mitigated. Findings will lay the groundwork for future interventions aimed at reducing stigma and its role in pediatric cancer care.

Public health relevance
Public Health Relevance This prospective study explores the ways in which stigma impacts decision-making and care acceptance for pediatric cancer patients, families, and providers in Guatemala, Jordan, and Zimbabwe, and seeks to identify potential strategies to mitigate stigma in these settings. This cross-cultural study will provide insight regarding the global manifestations of stigma in relation to childhood cancer, which thus far have been understudied. Ultimately, the findings of the study will inform the development of future adapted interventions aimed at reducing stigma and its role in pediatric oncology care in order to improve childhood cancer outcomes worldwide.